Vanderbilt Network Lead Academic Participating Site for the NCTN

PROJECT SUMMARY/ABSTRACT
Vanderbilt-Ingram Cancer Center (VICC) is a matrix cancer center within Vanderbilt University Medical Center
(VUMC). VICC has been part of the cooperative group system for over 30 years, and a Lead Academic
Participating Site (LAPS) since the inception of the National Clinical Trials Network (NCTN). Throughout the
years, we have integrated our physicians into leadership roles and our basic science into investigator-initiated
trials, as well as enrolled patients onto clinical trials. Additionally, VICC has a long track record of leadership,
both scientific and administrative, within the cooperative groups, and mentoring junior faculty in clinical trial
development. VICC brings great strengths to the NCTN, including two SPORE grants, an EDRN grant, eight
highly funded scientific programs, and an Early Therapeutics Clinical Trial Network (ETCTN) grant. Our
Personalized Cancer Medicine Initiative (PCMI) is dedicated to matching the appropriate therapy to the genomic
alterations that are driving the growth of cancers, with an active research component investigating mechanisms
of resistance to targeted therapies. VICC clinicians and scientists are academic leaders in their respective
disciplines and will continue to significantly contribute to the NCTN goals with the objective to improve the
outcomes for cancer patients. Kristen Ciombor, MD, serves as Principal Investigator and leads the efforts of the
institution to integrate its scientific, academic and patient resources into the NCTN. She has been involved
extensively in the cooperative groups/NCTN in conduct of clinical trials, including leadership and receipt of expert
mentorship. In recognition of her active engagement and leadership in NCI-funded collaborative clinical trials,
she was named a recipient of the 2021 National Cancer Institute Cancer Clinical Investigator Team Leadership
Award. Dr. Ciombor will leverage this experience and continue to successfully lead our NCTN program at VICC.
To assist Dr. Ciombor with the conduct of this grant, VICC created two advisory boards, Internal Advisory Board
(IAB) and NCTN Executive Committee (NEC), whose membership includes a broad representation of medical
disciplines and disease interests across VICC and VUMC. The IAB assures the optimal use of the grant, such
as budget review, assurance of multidisciplinary involvement, and participation throughout the NCTN. The NEC
implements operational functions, such as trial opening, accrual and mentoring. Operationally, the NEC has
actively managed NCTN trial opening, accruals and participation across disciplines and groups, including
identification of barriers for timely activation of NCTN trials. Both the IAB and NEC work to integrate VICC science
into the NCTN. The VICC Clinical Trials Office and its NCTN team ensures that regulatory, biospecimen,
radiology and data submissions are timely and highly accurate. This grant details the expert leadership and
mentorship that VICC faculty have provided to the NCTN cooperative groups.

Public health relevance
PROJECT NARRATIVE This supplement request provides the continued opportunity for Vanderbilt-Ingram Cancer Center (VICC) to participate in the National Clinical Trials Network (NCTN). It supports the infrastructure at VICC for the conduct of NCTN trials, thus allowing our investigators to collaborate with others around the country, to treat patients with novel cancer therapies, to serve in leadership roles within the NCTN, to bring scientific discoveries from VICC into NCTN trials and to mentor the next generation of clinical investigators in the NCTN system.